A Health Study of New York State Communities Exposed to PFAS Contaminated Drinking Water

Project Summary / Abstract
Per and polyfluorinated substances (PFAS) include compounds that are, or have been, manufactured in high
volumes for use in a wide variety of commercial and industrial products. A subset of PFAS are of particular
concern because they are very stable in the environment and accumulate in human serum/plasma. A person's
internal dose can continue beyond cessation of environmental exposure. PFOA and PFOS elicit a wide variety
of adverse effects in experimental models; however, epidemiological studies have observed mixed
associations due to methodological limitations and challenges. The objective of our proposed project, “A Health
Study of New York State Communities Exposed to PFAS Contaminated Drinking Water”, is to complete the
core protocol as prescribed by the CDC/ATSDR by developing a cohort from the greater Hoosick Falls and
Newburgh communities in New York State (NYS). In Hoosick Falls, PFOA levels in the public drinking water
supply were between 500 and 600 ng/L (ppt) in 2016. In Newburgh, samples of city drinking water showed
PFOS levels in excess of 140 ppt, PFHxS levels in excess of 70 ppt, and PFOA levels in excess of 25 ppt. We
also propose additional research projects that are responsive to these communities, while serving to enhance
the core protocol and inform future PFAS related hypotheses generalizable to other communities and study
sites across the U.S. For this project, we will (1) conduct historical dose reconstruction with PK modeling of
serum PFAS concentrations for the greater Hoosick Falls and Newburgh communities, including historical
municipal drinking water PFAS concentration modeling as needed; (2) enroll 2,175 study participants to cross-
sectionally examine health endpoints related to PFAS exposure in Hoosick Falls and Newburgh; and (3)
enhance the core protocol and inform future work by leveraging stored blood samples from recent PFAS
biomonitoring activities in these communities to prospectively measure PFAS and related health endpoint
changes over time and leveraging archived neonatal blood spots collected as part of the NYS Newborn
Screening Program and vital records to measure PFAS and immune function markers among core study
participants. This project will be conducted collaboratively between the University at Albany School of Public
Health (UASPH) and the NYS Department of Health (NYSDOH). The UASPH was created in 1985 as a unique
partnership with the NYSDOH; this partnership provides a platform for conducting large, statewide, prospective
cohort studies examining emerging issues, particularly among vulnerable populations. Together, we have
developed infrastructure for recruitment, tracking, and retention of our study populations. This existing
infrastructure and established community relationships will be leveraged to recruit a study cohort to examine
the health effects of exposure to PFAS contaminated drinking water.

Public health relevance
Project Narrative The proposed project will complete historical dose reconstruction of per and polyfluorinated substances (PFAS) in serum concentrations in residents of two communities with drinking water contaminated by PFAS. We will enroll 2,175 residents of Hoosick Falls and Newburgh, NY to examine health endpoints to better understand the long-term health consequences associated with PFAS exposure. We will explore these associations in adults and children.